Differential exon usage in single cell RNA-seq

Project Summary
Alternative splicing generates transcripts that vary between tissues and cell types, and
contributes to cell differentiation and organ development. Despite its importance in development and
cell identity, alternative splicing is usually neglected in single cell RNA sequencing (scRNA-seq)
analysis. This is due to the challenge in identifying confident alternative splicing events from scRNA-
seq data, which are limited in read-depth, and comes with large amount of noise due to variation in
molecule capture efficiency, amplification bias, and excessive zero-counts or dropouts. We propose
a novel approach to infer differential splicing based on short-read full-length scRNA-seq data,
utilizing read counts mapping to adjacent exons. In addition, we plan to systematically evaluate
existing approaches to answer questions on the strategy regarding the variable, pooling and
dispersion estimates. Finally, we will assess the accuracy of short read based methods by comparing
against scRNA-seq generated with new types of protocols. The work proposed will increase our
understanding on the utility and limitations of short read scRNA-seq data, and provide a better
pipeline for alternative splicing analysis in scRNA-seq.

Public health relevance
Project Narrative It is important to understand how specific transcript or protein isoforms contribute to the differentiation of cells to understand human development and disease. But, currently technical challenges exist to infer that information from the single cell RNA-seq data that is sparse and noisy. This project proposes to develop a novel method to infer differential exon usage for specific cell- types from smart-seq based single cell RNA-seq, and validate the method with data generated from alternative protocols.